MFRPS MAINTENANCE - TASKFORCE COOPERATIVE AGREEMENT- TX DSHS

MFRPS MAINTENANCE – FPTF PROJECT SUMMARY
MFRPS Maintenance: Program will (1) Maintain conformance with Manufactured Foods
Regulatory Program Standards by documenting corrective action and preventive action
in the strategic improvement plan (SIP); and conducting annual self-assessment of the
standards, including performance review of field inspections, inspection and sample
reports, and compliance/enforcement actions. Program will participate in FDA
assessments, and Division of Standards Implementation reviews of program. Program
will maintain a current SIP. Program will provide emergency response training for
inspectors. Training records will be moved into a learning management system for better
monitoring. Program will upload at least one policy required for a standard to the MFRPA
Portal or give a presentation at the annual MFRPA meeting. (2) Attend annual
Manufactured Food Regulatory Program Alliance meeting and participate in committees
and other initiatives. Program will maintain its FDA inspectional contract in good
standing. (3) Meet with FDA district office at least once per year to develop and monitor
progress in work planning, work sharing, and data exchange and will consider inspection
frequency for high risk and non-high-risk facilities. (4) Add a position to the MFRPS track
by separating the MFRPS coordinator duties from the program supervisor duties.
Program will participate on FDA calls specific to the Food Traceability Final Rule; will
meet partners to increase awareness of the rule; discuss impacts of the rule in Texas;
educate DSHS agency leadership; if applicable, complete rule writing and adoption
process; and educate food safety partners. Program will upgrade to the latest version of
the NFSDX data-exchange program and continue to participate in the data-exchange
work group. (5) Maintain 20.88 information sharing agreement with FDA. (6) Support
the Laboratory Flexible Funding Model (LFFM) with sampling plan development, violative
sample response, FDA notification, and funding for supplies. FPTF: (1) Hold at least one
task force meeting annually. (2) Hold at least one governance meeting of the task force.
(3) Annually report quantified metrics and measurements demonstrating the various
integration and task force activities conducted by the task force. (4) Submit copies of
materials developed in part by this funding to the Office of Partnerships. (5) Program will
provide funding for local health department travel to training and the FPTF meeting.

Public health relevance
MFRPS MAINTENANCE - TASKFORCE COOPERATIVE AGREEMENT- TX DSHS – RFA-FD-23-019 This project will facilitate the Texas Department of State Health Services’ efforts to protect public health by reducing and preventing instances of foodborne illness and food contamination. Food safety procedures and practices will continue to be standardized and improved through shared innovation, effective assessments, coordinated response, mutual reliance, and relationship building with our local, state, and federal partners. The project supports the efforts of Texas to move to an integrated food safety system.